Integrating Addiction and Infectious Diseases Services into Primary Care in Rural Settings

Abstract
The US strategy to End the HIV Epidemic calls for expanded prevention of new infections and more effective
responses to HIV outbreaks. These outbreaks often occur in counties and states that share a disproportional
burden of HIV, but the co-occurring and syndemic nature with opioid use disorder (OUD) leaves hundreds of
additional counties and regions highly susceptible to new HIV (and HCV) outbreaks. West Virginia (WV) is one
such mostly rural setting with an explosive opioid epidemic manifest by the highest per capita rate of overdoses
and 5 counties with recent HIV outbreaks. Evidence-based practices to prevent and control HIV in clinical settings
include medications for OUD (MOUD), ART treatment as prevention (TasP) and pre-exposure prophylaxis
(PrEP). Treatment with these medications, however, first requires screening and evaluation, followed by
treatment (SET). Adoption of SET processes may in turn translate to better health outcomes if adequately
facilitated. Most rural settings are poorly equipped to provide specialty HIV/HCV/OUD services – an important
lesson from Scott County, Indiana. Yet rural settings rely mostly on primary care clinics (PCC) with inadequate
expertise to provide these services. To overcome adoption barriers of SET processes for HIV/HCV/OUD,
effective facilitation is key and the NIATx treatment improvement strategy combined with ongoing clinical
education and support provided by Project ECHO has the potential to increase adoption to integrate specialty
HIV/HCV/OUD services into PCCs. Using the i-PARiHS implementation framework, we propose to address this
unmet need by first identifying barriers to adoption and scale-up of HIV/HCV/OUD services. Then we will facilitate
practice transformation by integrating clinical prompts in the electronic health record (EHR) to screen for
HIV/HCV/OUD, followed by treatment prompts. Treatment will be supported by Project ECHO that provides
ongoing clinical support to inspire confidence in treatment, alongside a clinical dashboard embedded within the
EHR as part of the quality performance improvement activities to sustain integrating HIV/HCV/OUD services into
PCCs. We then propose to conduct a stepped wedge, Type 3, hybrid implementation trial to assess the extent
to which clinicians adopt and sustain SET processes to integrate care at 20 PCCs that is facilitated by rapid cycle
change projects using NIATx. Adoption of SET processes are the primary outcome and a composite quality
health indicator (QHI) that combines QHIs for primary care, HIV, HCV and MOUD are secondary efficacy
outcomes. Organizational and clinician factors, along with engagement in facilitation activities (NIATx, ECHO
sessions) will be explored as potential mediators and moderators. Significance is high for the rural WV context
where a volatile opioid epidemic has ignited HIV/HCV outbreaks. Innovation is high by integrating HIV/HCV/OUD
services into PCCs using a framework and strategy we successfully used in urban international settings. Public
health benefits are high given the lack of knowledge known about integrating services into rural PCCs. Feasibility
is high based on the track record of an experienced team with interdisciplinary expertise and prior in WV.

Public health relevance
Project Narrative Ending the HIV Epidemic strategy requires being able to respond quickly to HIV (and HCV) outbreaks and scaling up evidence-based treatment and prevention. HIV outbreaks are often linked to the volatile opioid epidemic and occur mostly non-urban settings where specialty services are absent or limited. Consequently, creating models of integrated prevention and treatment for HIV, HCV and opioid use disorder in rural settings is urgently needed and can serve as a model for many vulnerable counties and states.